DETERMINATION OF GENETIC MUTATIONS IN ATYPICAL AND CANCEROUS BREAST LESIONS

It is still unclear the type of genetic alterations that patients with breast cancer have and (1) whether these alterations are different or similar to patients with familial history of breast and (2) whether these changes occur in pre-malignant lesions. Utilizing paraffin-embedded material and following the technique described by Sukpanichnant, we will search by PCR amplification for a variety of genetic alterations.